Obtaining brain pCO2, pH and pO2 maps via measurements of neurovascular coupling: a novel non-invasive approach to identify the culprits of loss of brain function

PROJECT SUMMARY
Brain function is critically dependent on the proper relationship of cerebral blood flow (CBF) and neuronal
metabolic demands, a phenomenon referred to as neurovascular coupling. Pathological reductions in CBF are
commonly observed in presence of loss of brain function, but paradoxically there is often sufficient oxygen supply
to support function. Answering this paradox not only would help understand the loss of brain function, but would
also provide important new insights into how to interpret fMRI, which essentially measures neurovascular
coupling, at the network down to the microscopic level of brain function. I propose to answer these longstanding
questions, via a new approach. Rather than following the decades old path of focusing almost exclusively on
oxygen delivery and its coupling to neuronal activity, I will develop and validate imaging methods and
mathematical models for studying how neurovascular coupling maintains homeostasis of all of the substrates
and products of functional brain metabolism. The importance of maintaining tight regulation of the levels of the
metabolic products CO:i and protons, have long been recognized via EEG/MEG studies of respiratory hyper and
hypocarbia; yet CO2 and protons homeostasis are mosUy disregarded, likely because non-invasive
methodologies that allow their assessments are lacking. My goal is to fulfill this unmet need, and establish a
transformative neuroimaging approach that quantifies non-invasively oxygen availability, pH and carbon dioxide
accumulation in brain tissue. Achieving this goal requires comprehensive studies and theoretical understanding
ranging from microscopic capillary transport to the regulation of systemic physiology, at the center of this project.
Here my efforts will pivot to a new direction of unprecedented studies that will combine positron emission
tomography (PET), optical imaging, MRI, implanted biosensors, and theoretical modeling. My colleagues and I
have already conceptualized the highly innovative framework that grounds the studies of this proposal. In
particular, by connecting for the first time the properties of neurovascular coupling to the needs of waste removal
originating from the metabolic processes linked to neurotransmission, we paved the way towards accurate
calculations of oxygen availability, pH and carbon dioxide accumulation from routine MRI measurements. Such
a methodology has a tremendous potential to transform the scope and breadth of basic and clinical investigations
of the brain (and beyond}, however rigorous validations are sorely needed in order to realize its potential. By
capitalizing on recent advances in imaging platforms available at the CMRR and in partner institutions which I
have been collaborating with for years, the time is mature to conduct the proposed high-risk, high-impact studies
that can only be executed within the flexible scheme of a Pioneer award. Focusing on pathological mechanisms
linking loss of brain function to abnormal accumulations of metabolic waste products, and on non-MRI techniques
for validation studies, requires a major research shift for me, but is essential for building the foundation of a much
broader agenda that will benefit the basic and translational neuroscience community and ultimately patient care.

Public health relevance
PROJECT NARRATIVE By capitalizing on recent new insights into brain neurovascular coupling, the goal of this project is to establish and validate a transformative neuroimaging approach that quantifies non-invasively physiological metrics fundamental to brain function, such as oxygen availability, pH and carbon dioxide accumulation in tissue. The project represents a novel direction of research for Dr. Mangia, who will conduct pioneering studies using the proposed novel neuroimaging approach to explore an innovative conceptual framework linking loss of brain function to abnormal accumulations of metabolic waste products.